Cell-intrinsic and contextual determinants of aging by human glial progenitor cells

Abstract Glial progenitor cells (GPCs) pervade the adult human brain, and can give rise to new oligodendrocytes
and astrocytes in response to myelin loss; yet they may fail to do so in chronic neuroinflammatory and age-
related white matter diseases. Our goal is to identify the transcriptional and epigenetic basis for age-related glial
progenitor failure, with the goal of identifying the repressive transcription factors and epigenetic states that restrict
progenitor cell expansion and differentiation with age. By targeting these repressive networks, we hope to restore
the functional viability of human GPCs, and by so doing prevent the myelin loss that characterizes both aging
and those neurodegenerative and inflammatory disorders associated with white matter disease. By so doing, we
hope to preserve not only the differentiation competence of the cells, but also their self-renewal, so that myelin-
ogenesis may be induced from hGPCs without the progenitor depletion to be expected of strategies designed to
trigger terminal oligodendrocytic differentiation. Achieving this in human GPCs, which differ substantially in their
biology from mouse, and doing so in vivo, has proven a significant challenge to the field. To this end, we will ask:
1. To what extent is the aging of human ESC-derived GPCs cell-intrinsic and linked to prior cell division,
both in vitro and in vivo? What are the transcriptional and epigenetic concomitants to hGPC aging in vivo, and
which of these restrict hGPC expansion and differentiation? How do hGPCs, extracted back from neonatally-
transplanted human chimeric mouse brains, change in their DNA methylation patterns, their ATAC-Seq-defined
patterns of chromatin accessibility, and their consequent RNA expression, over the 2-year lifespan of a mouse?
2. To what extent are the effects of aging on hGPCs a function of the aged brain environment, rather than
cell autonomous? In order to define the relationship of hGPC cell age to expansion and myelination competence
- and the extent to which the age of the host influences hGPC fate – these experiments will include a set of
reciprocal, heterochronic transplants, grafting aged cells into neonates, and new hGPCs into aged brains.
3. In aged GPCs, can genetic knock-down of those repressors implicated in the progression to adult
hGPC phenotype restore the transcriptional signature, as well as the expansion and differentiation competence
in vivo, of younger hGPCs? Is suppression of MAX, potentially together with a core set of other over-expressed
repressors, sufficient to restore MYC-dependent mitotic expansion and host colonization by aged hGPCs?
With this work, we expect to establish a granular understanding of the relative roles of cell-intrinsic, expansion-
dependent senescence and host context in regulating the proliferation and remyelination competence of human
GPCs. Furthermore, if the introduction of young hGPCs into an aged environment allows the selective
colonization of the host white matter by those younger hGPCs, the implications may be profound, as disorders
as varied as progressive multiple sclerosis and the neurodegenerative disorders might then become potential
targets of cell replacement strategies based on the competitive advantages of young over aged glial progenitors.

Public health relevance
Project Narrative Our goal with this work is to identify the basis for the progressive white matter loss that characterizes aging, with a focus on the failure of remyelination by glial progenitor cells (hGPCs) that attends both aging and age-associated neurodegenerative disorders. We will do so by establishing human glial chimeric mice with embryonic stem cell-derived hGPCs that have been subjected to serial mitotic expansion in vitro before transplant, comparing the in vivo colonization and myelination competence of hGPCs of different ages, and as a function of time after neonatal engraftment; conversely, we will transplant young hESC GPCs into older adult brains, and compare their expansion and differentiation competence to that of aged hGPCs in the same grafts. We will then use RNA sequence analysis – both bulk and single cell - together with both ATAC-Seq determination of chromatin occupancy, and measures of DNA methylation state and telomeric length, to define the effect of aging on the transcription and epigenetic state of hGPCs in vivo, our goal being to define and target those age- associated repressors that may delimit hGPC competence, and by suppressing their expression, to restore the expansion and fate competence of aged human glial progenitor cells.